Efferocytosis-Directed Inflammation Resolution and Repair in the Hypoxic Heart

Thorp Project Summary Abstract
Cardiac injury and heart failure are significant causes of morbidity and mortality. Enhanced
therapeutic strategies that are informed by new discoveries in the fundamental mechanisms of
biology have the potential to enhance tissue repair and improve health. Diverse risk factors
including age, sex, diet, and hypertension can affect disease outcome. Within this framework,
common underlying factors of disease progression are inflammation and cells of the innate
immune system. This includes myeloid phagocytes, which have the capacity to be either
cardioprotective or cardiopathogenic. After myocardial injury, the extent of inflammation and the
activation state of myeloid macrophages have been linked to the degree of myocardial stress,
cardiac fibrosis, and cardiac performance. One explanation for this is the ability of macrophage
subsets to secrete potent cytokines which regulate the activity of nearby cells, such as
parechymal, stromal, and neighboring immune cells of the heart. Our studies will identify novel
roles for macrophage subsets and intercellular crosstalk by signaling through vascular
endothelial growth factors, as well as integrated contributions of mitochondrial
immunometabolism.

Public health relevance
Thorp Narrative Lay Suboptimal inflammatory responses in the heart are characteristic of a diverse array of pathologies, including cardiac injury and cardiometabolic heart failure. Common to these pathologies is activation of myeloid phagocytes, which due to their heterogeneity and plasticity, have the capacity to either promote or resolve inflammation through cellular crosstalk. This proposal will identify novel regulatory pathways in macrophage subsets that causally modify cardiac inflammation.